The Influence of Aerodynamic Particle Size on the Virulence of Aerosolized SARS-CoV-2 Virus

To perform studies to determine the influence of aerodynamic particle size on the virulence of aerosolized virus.